Development of an all-in-one soft wearable device for accurate lung function detection and asthma diagnosis

PROJECT SUMMARY
The extensive heterogeneity with differing underlying pathological processes and symptoms that overlap
with a wide range of disease processes make correct diagnosis of asthma difficult and contribute to the
challenges in treatment and care of asthma. Consequently, confirming one’s diagnosis of asthma
involves a long and sophisticated diagnostic workflow involving multiple tests and interpretation of results,
the process of which is available only to dedicated pulmonary care facilities. Instead, for majority of cases,
patients with symptoms suspected of asthma visit primary care offices for initial assessment based on
office-based portable spirometers. However, recent studies show that many office-based spirometers
showed variable performance in “real-world” settings and produced mixed results in primary care settings.
Given the central role of spirometry data in the diagnosis of asthma and treatment decision, suboptimal
performance of spirometry in primary offices might contribute to misdiagnosis or delayed diagnosis. The
main drawback of current portable spirometers is it requires extensive user focus and effort, such as
expiring as quickly and long as possible, biting the mouthpiece and sealing it with the lips, and blocking
the nostrils with a nose clip, all contributing to test results with high inter-trial variability. The research
team hypothesizes that a new measurement tool that is much less dependent on user’s effort and easier
to use will result in the more consistent and reliable measurement of lung functions. Therefore, in this
study, we propose the following specific aims to develop a novel wearable sensor that can be attached
to the user’s body to generate metrics comparable to standard lung function parameters (FVC, FEV1, and
PEF): 1) Develop a soft wearable device for high-fidelity auscultation and chest movement detection. 2)
Correlate sound data and lung function parameters to develop a lung function estimation algorithm. 3)
Validate device performance and usability in a clinical setting with patients. We will identify the correlation
between the sensor data (lung/airway sounds and chest accelerometry) and standard lung function
parameters provided by a portable spirometer. Through this, a lung function estimation algorithm will be
developed. A mobile application that processes the sensor data in real time will also be developed to
enhance user engagement and to ensure each maneuver is performed correctly even in the absence of
human coaching. Feasibility to use the sensor system in a clinical environment as well as their
performance as a reliable lung function assessment tool will be validated with patients visiting a doctor’s
office for pulmonary issues. The successful completion of this study will lead to the development of a new
lung function assessment method that requires less user effort and is more reliable than spirometry
performed in primary care settings. Advances in the mean to assess lung functions in primary care offices
will improve the accuracy of asthma diagnosis, care, and ultimately patient outcome.

Public health relevance
PROJECT NARRATIVE Lung function measurement based on portable spirometer used in a primary care setting has shown to be variable and less reliable than spirometry done in a full pulmonary function test laboratory. Since spirometry results are used to make clinical decisions in the diagnostic workflow of asthma, there is a significant risk of misdiagnose or under-/over-treatment of asthma. In this study, we propose to develop a soft wireless patch that a user can apply on the chest to measure lung function parameters equivalent to conventional spirometry but with significantly decreased level of user’s effort and enhanced consistency in test results.